Investigating the mechanisms of Arc‐dependent synaptic plasticity

Abstract
Synapses are the basis of neuronal communication and plasticity. Decades of research in reduced preparations
have revealed fundamental principles of neuronal transmission and synaptic plasticity. This work identified key
molecular constituents of synapses and pre- and postsynaptic mechanisms underlying activity dependent
changes in synaptic transmission. Now, technological advances in optical manipulation and read-out
technologies have opened the door to studying the role of synapses in-vivo. Thus, allowing dissection of synapse
function from neuronal circuits to cognition.
Synaptic plasticity is integral to development and experience-dependent changes in the brain. While there have
been attempts to link synaptic plasticity mechanisms discovered in reduced preparations to in-vivo function such
as memory formation, important challenges and questions remain. How do the longer time scales of behavioral
memory formation and the corresponding in-vivo synaptic changes relate to the relatively short time scales of
synaptic transmission and plasticity? What role does synaptic plasticity play in the formation and updating of
large-scale neural networks (internal models) underlying cognitive processes involving prospective planning and
inference? How is information maintained in neural circuits in the face of dynamic and changing synaptic
architecture in the developing and adult brain? How do non-neuronal cells such as astrocytes and microglia
contribute to synaptic function and plasticity? When and how can our understanding of basic mechanisms of
synaptic function be used to develop treatments for debilitating psychiatric disorders?
Coming out of the global coronavirus pandemic this meeting is particularly relevant as the usual lines of
international scientific communication and collaboration were cut and research endeavors became isolated.
Trainees and junior faculty were particularly hard hit during this time as their ability to network and collaborate
across borders was severely curtailed. In-person, face-to-face scientific interaction and discussion is needed
now more than ever. Our meeting will bring together scientists from the US and Japan at many stages of career
development to re-energize global scientific exchange between our two countries. Our goals are to share in
recent scientific successes and, most importantly, identify new directions for the field which will spark innovation
and collaboration.

Public health relevance
Relevance Synaptic plasticity is integral to development and experience-dependent changes in the brain. While there have been attempts to link synaptic plasticity mechanisms discovered in reduced preparations to in-vivo function such as memory formation, important challenges and questions remain. We are now at the point of being able to address these important questions, but the challenge of integrating molecular mechanisms to behavior remains. Global collaboration between molecular and cellular biologists, technology developers and systems neuroscientists is critically important to connect mechanistic level knowledge of synaptic function to in-vivo behavior.